Renal Research Training Program

? DESCRIPTION (provided by applicant): This application requests five years of continued support for our postdoctoral training program in research relevant to the kidney. The overall goal of this program is to develop skilled investigators trained to conduct research in clinical science translational science or bench science, and capable of academic careers as independent researchers. This program represents collaboration between Penn's adult and pediatric renal divisions, and its many biomedical research programs intended to develop future academic leaders in nephrology. Our program is designed to support two years of salary and tuition costs for six MD, MD-PhD, (or rarely PhD) post-doctoral fellows per year, who typically have completed training in either adult or pediatric clinical nephrology. Our training program has evolved to meet current scientific challenges facing the wider renal community. We recognize that this requires a program that brings together multiple disciplines and mentors. We have adapted to meet this challenge through recruitment of outstanding faculty mentors from multiple disciplines; by providing access to master's degree programs in three areas of clinical or translational research; by engagement of experienced scientists in related disciplines to interact with our faculty and supervise our trainees, and through the provision of the framework, environment and means to accomplish these goals.

Public health relevance
PUBLIC HEALTH RELEVANCE: Kidney disease is a leading cause of suffering and death in the United States. The Penn Renal Research Training Program is intended to train post-doctoral fellows in the experimental approaches and science necessary to address these devastating problems.